Structure-Function Studies of the Human Cytochrome P450 27 Family

The human cytochrome P450 (P450) enzymes are monooxygenases involved in the metabolism of
steroid hormones, pharmaceuticals, carcinogens, and fat-soluble vitamins. P450 enzymes therefore have many
direct impacts on human health. The study of P450 enzymes has led to several important advances in medicine
including new therapies and the safer use of existing therapies. One important, yet understudied family of human
P450 enzymes is the 27 family including P450 27A1, 27B1, and 27C1. These enzymes catalyze the oxidations
of several important lipophilic hormones including vitamin D derivatives (27A1 and 27B1), cholesterol derivatives
(27A1), and retinoids (27C1). The products of these reactions can have either positive or negative effects on
human health depending on their concentrations in the body. Therefore, it could be valuable to either increase
or decrease these enzymes’ activities for clinical therapies. This research project focuses on how the structure
of the enzymes determines their function. In particular, we are interested in how the interactions between the
P450 enzymes and the redox partner protein adrenodoxin can alter enzyme structure and in turn P450 function.
We are also interested in the development of uncompetitive drug therapies that can act more selectively to
prevent enzyme activity by altering enzyme structure. We propose that a thorough mechanistic description of
the P450 27 family structure-function relationship will inform the development of new and safer therapies
involving these enzymes and various cancers, hormone regulation, and bone health. The focus on lipophilic
hormones is in line with the overall vision of the laboratory examining the function of other membrane-associated,
lipid-active enzymes for the sake of developing new clinical therapies. Over the next five years, the goals of the
laboratory include applying structural approaches novel to the study of P450 enzymes like small-angle X-ray
scattering and small-angle neutron scattering, applying classic structural approaches to P450 enzymes like X-
ray crystallography, determining the effects adrenodoxin has on P450 function, and testing the ability of known
P450 27A1 inhibitors to act in an uncompetitive manner. To accomplish these goals, we will expand our
laboratory personnel while maintaining a focus on undergraduate research training. In total, the laboratory seeks
to improve human health by increasing our basic understanding of enzyme function and by working to embrace
diversity in training the next generation of biomedical scientists.

Public health relevance
The human cytochrome P450 enzymes P450 27A1, 27B1, and 27C1 are involved in the metabolism of endogenous hormones and vitamins. There is little known about the structures of these enzymes and how these structures change during the reactions the enzymes catalyze, making it difficult to develop clinical therapies that alter the activity of these enzymes. This research project seeks to enable the design of new and safer therapies for various diseases effected by hormone or vitamin levels by providing a more thorough description of how the structure of these enzymes affects their function.